Neuronal Silencing of ATXN3 Using Peripherally Administered Antibody/ASO Conjugates That Penetrate the Blood-Brain Barrier

SCA3, also known as Machado–Joseph disease, is the most common dominantly inherited ataxia in the world.
The mutant SCA3 disease protein, ATXN3, acts through a dominant toxic mechanism, and mice lacking ATXN3
are phenotypically normal. Thus, suppression of the disease gene, ATXN3, represents a promising approach to
slow or block the neurodegenerative cascade in SCA3. Anti-sense oligonucleotides (ASOs) represent a nonviral
gene suppression approach that has emerged as a compelling therapeutic strategy for treating SCA3 and other
neurodegenerative disorders. However, this approach suffers from three main limitations: i) highly invasive
(intrathecal or intracerebroventricular) route of administration; ii) poor deep brain penetration, and iii) lack of cell-
specific targeting. The goal of this proposal is to address each of these limitations using bispecific antibodies
conjugated to ASOs (bAb-ASOs) to enable: i) intravenous administration; ii) efficient transport across the intact
blood-brain barrier (BBB) and deep and widespread brain penetration; and iii) selective targeting of neurons
using antibodies that target cell-surface proteins that mediate neuron-specific internalization and intracellular
release of ASOs. Our approach has three main components. First, we use a validated IgG (M6) specific for a
neuronal membrane protein (Neuronal Glycoprotein M6a) that is highly conserved within mammals and highly
expressed in the brain. Second, we genetically fuse a single-chain antibody to the C-terminus of the IgG M6 that
recognizes an understudied BBB target for mediating efficient transport into the brain parenchyma, namely
CD98hc. Third, we attach ASOs to the M6/CD98hc bispecific antibody that will be released after antibody
internalization and mediate gene silencing. The overall objective of the current proposal is to establish the
feasibility of using bAb-ASOs to silence disease-specific neuronal genes in transgenic mice and suppress
disease phenotypes. Our central hypothesis is that the bispecific antibody will enable delivery of ASO across the
BBB and into neurons, resulting in cell-specific gene silencing and improvement in disease severity. To test this
hypothesis, we will first evaluate PK/PD of bAb-ASO conjugates and silencing of ATXN3 (Aim 1). We will
conjugate our validated M6/CD98hc bispecific antibodies to an optimized ATXN3 ASO and test in cell culture.
For in vivo analysis, we will use the YAC SCA3 transgenic mouse line, which harbors the full human SCA3
disease gene and recapitulates molecular and behavioral features of SCA3. We will perform PK/PD analysis to
evaluate the silencing of ATXN3 protein and the duration of this effect with repeated dosing. Next, we will
evaluate the efficacy of silencing ATXN3 using bAb-ASOs in mouse models of SCA3 (Aim 2). We will directly
compare the efficacy of peripherally delivered bAb-ASO conjugate to that of intracerebroventricular injection of
the naked ASO in aging SCA3 mice to determine whether peripherally delivered bAb-ASO conjugate prevents
the development of disease-associated phenotypes and, if so, whether the efficacy equals or surpasses that of
naked ASOs.

Public health relevance
The goal of this proposal is to improve the delivery of agents (anti-sense oligonucleotides), which are capable to silencing neurogenerative disease-specific genes, to neurons without the need for invasive methods of administration. This research will involve conjugating anti-sense oligonucleotides to antibodies that penetrate the intact blood-brain barrier, target cell-surface neuronal proteins, and release their conjugated agents after antibody cellular internalization. Successful completion of this research would accelerate the development of therapeutics for treating diverse neurodegenerative disorders.